GABAc Receptors & Mouse Retinal Ganglion Cell Responses

at bhetop of each _ _ _ _ __ _ RESEARCH GRANT TABLE OF CONTENTS Page Numbers Face Page .................................................................................................................................................. 1 Description,